GH21-001, Conducting Public Health Research in Thailand: Technical collaboration with the Ministry of Public Health (MOPH) in the Kingdom of Thailand

Project Summary/Abstract
The collaboration between CDC and Thailand MoPH have led to breakthroughs in research, improved
programmatic practices and strengthened laboratory system. This is an umbrella Cooperative Agreement that
will facilitate collaboration between Programs/Divisions within CDC Thailand and Thailand MoPH for the
conduct of Public Health research on diseases of importance to both the United States and Thailand. The
Permanent Secretary of Thailand MoPH is the Principle Investigator (PI) for this Research Cooperative
Agreement and assigned Director of Strategy and Planning Division (SPD) to be business official will oversee
project implementation and management through the project period respectively.
The overall objectives of the MoPH CoAg project is to conduct epidemiologic, clinical field and laboratory
research on important human infectious diseases, with emphasis on HV/AIDs, malaria, emerging and re-
emerging infectious diseases, zoonotic diseases, , neglected tropical diseases, tuberculosis , influenza,
coronaviruses and other diseases with pandemic potential, research on mobile and vulnerable populations
including environmental health, chronic diseases, birth defects and developmental disabilities, maternal and
child health, public health preparedness, biosafety and injury control and prevention. Results of this research
project will be incorporated into operational system, surveillance, diseases control and prevention program in
Thailand, including capacity building and sharing data to other agencies.
In this application, the MoPH has proposed total of 12 projects, which comprised of 6 new projects and 7
continuation projects under programs as following:-
1. Coordinating Unit- CU1-MoPH The Ministry of Public Health Coordinating Unit(Continuation)
2. The Division of Global Health Protection (DGHP)- 2 projects: DGHP-AFINGS-BIDI (New) and DGHP-
Sepsis-NGS (New)
3. Division of HIV/AIDS Prevention (DHAP)- 5 Projects: DHAP-COSERO (New), DHAP-HPTN083
(Continuation), DHAP-Main (Continuation), DHAP-TGW (Continuation), DHAP-ZOLI (Continuation)
4. Division of Global Migration and Quarantine (DGMQ)- 1 project: DGMQ-MNPC (New)
5. Non-Communicable Diseases (NCD)- 1 Project: FETP-NCD (New)
6. Influenza Program (FLU)- 2 projects: FLU-COVID-EPBI (Continuation), Flu-Serology (Continuation)
Please see details of each project in attached file name-

Public health relevance
Project Narrative Thailand Ministry of Public Health proposes research application on “Conducting Public Health Research in Thailand Technical Collaboration with the Ministry of Public Health (MoPH) in the Kingdom of Thailand”. The project is comprised of 12 projects under various programs: Administration and Management, DGHP, DGMQ, DHAP, NCD and FLU. Please see details of each project in attached file name-Project Narrative for Thailand MoPH Research CoAg-RFA-GH-21-001